Project 3

Summary
Acute ischemic injury, such as myocardial infarction (MI), is a major contributor toward the development of heart
failure (HF), a progressive disease affecting millions of patients and costing billions of dollars annually. Myeloid
cells, such as neutrophils, monocytes and macrophages, are rapidly recruited to (peripheral blood leukocytes,
PBL) or activated within (tissue resident macrophages, TRM) the heart following acute injury or stress where
they regulate a wide variety of cardiac remodeling responses. Additionally, macrophages secrete numerous
paracrine factors to influence their surroundings such as extracellular vesicles (EVs), which includes small 40-
150 nm EVs termed exosomes. We previously demonstrated that the β2-adrenergic receptor (β2AR) is a critical
regulator of immune cell responsiveness to cardiac injury, but with limited mechanistic insight, particularly with
respect to myeloid cells, including macrophages. We have thus focused on defining the impact of β2AR deletion
specifically in myeloid cells on cardiac function and remodeling following injury. We have developed a mouse
model with myeloid cell-specific constitutive β2AR deletion (LysM-Cre/β2ARf/f; LB2), which exhibit less
maladaptive remodeling following MI, including reduced expansion of dead cardiomyocytes and increased
neutrophil clearance, resulting in preservation of cardiac function and reduced fibrotic remodeling. Various
myeloid cells isolated from LB2 mice, and PBL from human HF patients chronically taking β-blockers, were found
to express higher levels of genes involved in the regulation efferocytosis/phagocytosis, which are known to
functionally enhance apoptotic cell clearance and promote cardiac repair. Additionally, exosomes isolated from
β2AR-defcient BMDMs contain less inflammatory and more pro-angiogenic factors and induced greater
endothelial cell capillary tube formation in vitro. When injected intramyocardially at the time of MI in wild-type
mice, β2AR-deficient BMDM-derived exosomes stabilized cardiac function as compared to PBS- or WT
exosome-injected mice, which was associated with decreased fibrosis and improved capillary density. Overall,
we hypothesize that β2AR deletion results in alterations within myeloid cells, including macrophages and their
exosomes, that promote beneficial cardiac remodeling responses following injury. In Aim 1 we will determine
the mechanisms by which myeloid cell-specific β2AR deletion enhances cardiac repair following injury, with a
focus on efferocytosis and cardiac TRM. In Aim 2 we will investigate whether clinically used β-blockers induce
comparative alterations in both PBL and cardiac TRM and if these changes are observed in the PBL of human
HF patients. In Aim 3 we will characterize the properties of β2AR-deficient macrophage-derived exosomes that
promote angiogenesis and stabilize cardiac remodeling. Overall, the goal of this project is to define how myeloid
cell-expressed β2AR regulates cardiac function and remodeling after injury, attain a fundamental understanding
of the mechanisms by which macrophage-derived exosomes contribute to these processes and determine
whether β2AR-selective therapeutics can regulate their contents and impact on injury.

Public health relevance
Narrative Acute ischemic injury, such as myocardial infarction (MI), is a major contributor toward the development of heart failure (HF), a progressive disease affecting millions of patients and costing billions of dollars annually. Myeloid cells are rapidly recruited to or activated within the heart following acute injury or stress where their regulation of cardiac function and remodeling are sensitive to β2-adrenergic receptor (β2AR) activity. The goal of this project is to define how myeloid cell-expressed β2AR regulates cardiac function and remodeling after injury and whether β2AR-selective therapeutics can regulate the myeloid cell-specific impact on injury.